A Functional Taxonomy of Cortical Astrocytes

PROJECT SUMMARY/ABSTRACT
Recent work has solidified the concept that astrocytes are critical circuit components that regulate
neuronal activity, particularly synchronous types of activity. However, it remains unclear how astrocytes
encode and integrate neuronal circuit signals to mediate this neuronal synchronization. Moreover, the extent to
which single astrocytes function as individual computational units or operate as a syncytial network is not well
understood. In the proposed research, we aim to address these gaps in knowledge by uncovering both the
mechanisms by which neuronal signals are differentially transmitted to astrocytic networks, and those by which
astrocytes feedback to neuronal networks. We will focus on the two major neurotransmitters in the cerebral
cortex (glutamate and GABA) and one essential neuromodulator, norepinephrine (NE), since astrocytes
express abundant cell-surface, G-protein coupled receptors that are activated by all three of these neuron-
derived signals. We will use both ex vivo cortical slices and in vivo mouse models, and apply optical,
electrophysiological, chemogenetic, and genetic techniques to test astrocytic integration into these signaling
systems. Our goals are three-fold: We will determine 1) the mechanisms by which single astrocytes respond to
subcellular activation of glutamate, GABA, and NE, and how those dynamics shape an astrocytic output, 2) the
spatiotemporal effects on local neuronal and astrocytic networks of these three
neurotransmitters/neuromodulators, and 3) the mechanisms by which astrocytes transmit cortex-wide signals
to neurons. Thus, in each of the three aims, we will probe similar mechanistic questions at progressively wider
neurobiological scales.

Public health relevance
PROJECT NARRATIVE While astrocytes are now recognized as integral neural circuit components, a fundamental description of their input-output function—and a comprehensive understanding of astrocytic responses to major neurotransmitters—remains elusive. In this proposal, we focus on astrocytic responses to three major neurotransmitters to ask how neurotransmitter-specific activity leads to cell- and network-level activity across three progressive neurobiological scales. Our results will illuminate mechanisms by which astrocytes encode neurotransmitter signals and coordinate neural populations across the cerebral cortex.